Mechanisms of elesclomol-mediated copper delivery to cuproenzymes in cells

PROJECT SUMMARY
Copper (Cu) is an essential micronutrient that is required for growth and development of humans. The
requirement of Cu is attributed to its role as a catalytic cofactor for a number of enzymes involved in various
physiological processes, including mitochondrial energy production, neurotransmitter biosynthesis, and
connective tissue formation. Owing to its diverse roles in cellular and organismal physiology, loss-of-function
mutations in genes required for Cu absorption or transport to cuproenzymes often result in fatal infantile
disorders. For example, defects in the steps involved in the mitochondrial Cu delivery pathway to cytochrome c
oxidase (CcO), a mitochondrial cuproenzyme, are associated with a subset of mitochondrial disorders, while
disruption in delivering dietary Cu to different organ systems results in Menkes disease. Currently, therapies for
these diseases are experimental and largely ineffective at preventing early mortality. To identify compounds
that can deliver Cu to cuproenzymes and thus overcome these defects, we performed a targeted screen for
Cu-binding pharmacological agents and identified elesclomol (ES) as a potent Cu-transporting molecule. Our
initial studies have shown that low nanomolar concentrations of ES can deliver Cu to CcO in yeast, zebrafish,
and mouse models of Cu deficiency. Having made this breakthrough, we are now in position to test our
hypothesis that ES, which was originally developed as a cancer drug, can be repurposed to safely deliver Cu
to different cuproenzymes and rescue disease phenotypes associated with Cu deficiency disorders. To do this,
we will first determine where and how ES releases Cu inside cells and whether this can be achieved without
damaging cells. Second, we will utilize our newly constructed zebrafish models with specific defects in
systemic or mitochondrial Cu metabolism and a mouse model of Menkes disease to test the efficiency of ES in
rescuing mitochondrial, cellular, and organismal phenotypes by delivering Cu to cuproenzymes. Thus, the
proposed work will uncover the mechanism of ES-mediated intracellular Cu transport and advance a promising
therapeutic molecule for the treatment of debilitating and frequently fatal Cu deficiency disorders.

Public health relevance
PROJECT NARRATIVE Genetic defects that impair copper transport to copper-containing enzymes referred to as cuproenzymes result in fatal disorders in young children. Currently, no effective therapy exists for these disorders mainly because we lack compounds that can safely deliver Cu to the cuproenzymes. This project will investigate whether elesclomol, a cancer drug that we have shown to transport copper to mitochondrial cuproenzymes, can be safely used to deliver copper to non-mitochondrial cuproenzymes and alleviate disease symptoms in animal models of human copper deficiency disorders.